Brief Acceptance-Based Retention Intervention for Newly Diagnosed HIV Patients

Project Summary/Abstract
Drop-out rates from medical clinics in the first months following linkage to HIV care are as high as 50%,
with 31-46% of patients dropping out after the first visit. People Living with HIV (PLWH) who are not
consistently retained in care are at risk for: delayed antiretroviral treatment (ART) initiation, reduced ART
adherence, unsuppressed viremia, and mortality. Moreover, poor retention means effective ART cannot be
leveraged to prevent further HIV transmission. The long-term goal is to improve the HIV care cascade by
developing behaviorally-based interventions with broad applicability that can be executed with minimal cost
and effort in community-based HIV care medical settings. The objective of this proposal, which is the next step
in attaining the long-term goal and building on our successful R34 study, is to conduct a fully powered,
randomized controlled trial (RCT) to assess the efficacy of a brief, 2-session acceptance-based behavioral
therapy (ABBT) intervention to enhance retention in HIV care. The central hypothesis is that participants'
informed disclosure of HIV status to members of their support system, facilitated through increased
acceptance of HIV status early in medical care, will increase their longitudinal commitment to care.
The aims of this proposal are: (1) To test, in a 2-arm RCT, the efficacy of the ABBT intervention on
retention in care and virologic suppression (primary outcomes); and, ART adherence, disclosure of HIV status,
perceived social support, HIV stigmatization (secondary outcomes), relative to an Enhanced-Treatment-as-
Usual condition; and, (2) To examine the degree to which retention in HIV care and virologic suppression are
mediated by (a) increased HIV acceptance (and decreased HIV experiential avoidance) and (b) increased
willingness to disclose HIV status. The sample will consist of 270 HIV patients who are new to care, recruited
from two large, geographically and ethnically diverse HIV medical care settings in Providence, R.I., and New
Orleans, L.A. The approach is innovative in that it departs from the status quo by using brief acceptance-based
psychotherapy techniques, delivered in-person and by telephone, to increase acceptance of HIV status and
promoting careful and thoughtful serostatus disclosure as a specific mechanism to support retention and
virologic suppression. Upon successful completion of the proposed R01 research, this study will contribute
significant actionable data clarifying the impact and mediational mechanisms of ABBT on medical care
retention and virologic suppression. Thus, it will lay the groundwork for the dissemination of a simple, low-cost
intervention that can be integrated into usual HIV care.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because improving medical care retention and virologic suppression among new HIV patients is ultimately expected to reduce the prevalence of the myriad problems that are associated with untreated or poorly managed HIV, including the spread of HIV. Thus, the proposed research is relevant to NIMH's Division of AIDS Research's objectives that pertain to improving the HIV care cascade and reducing patient drop-out.